Enhancing dissemination and career development in sex and gender translational science in alcohol use

Project Abstract
Alcohol use among women has substantially and concerningly increased over the last decade, relative to
smaller increases among men. While drinking is strongly associated with significant health risks in both sexes,
females have exacerbated alcohol-related health consequences when compared to males. Compounding this
issue, treatment development for alcohol use has not considered, nor is responsive to known sex differences in
alcohol use. For these reasons, the field requires an increased capacity to conduct translational science to
study sex and gender differences in relation to alcohol use. This R13 proposal is a request for funding for a bi-
annual (once every two years), one-day satellite meeting held at the site of the Research Society on Alcohol
conference to focus on translational innovations in sex and gender differences in alcohol use. This meeting
would serve several key functions: 1) To serve as a hub for an international group of scientists, clinicians, and
trainees to support the exchange of ideas and promote new collaborations on sex/gender and alcohol use
spanning T1 to T4 translation. 2) To foster the development of the next generation of translational alcohol
researchers, by supporting 25 travel awards to graduate students, postdoctoral fellows, and early-career junior
faculty to present their research. 3) To provide information on best practice procedures and definitional
parameters relevant to the study of sex/gender and alcohol. An interactive program would feature both leading
international speakers and trainees, maximizing diversity and inclusion. This proposed R13 grant will provide a
unique contribution to NIAAA’s mission to incorporate sex and gender “into the design, analysis, and scientific
reporting of the studies it funds. This is a critical step toward ensuring that everyone, regardless of sex or
gender, benefits from alcohol research advances”32.

Public health relevance
Project Narrative Alcohol use among women has substantially and concerningly increased over the last decade, relative to smaller increases among men. This R13 proposal is a request for funding for a bi-annual (once every two years), one-day satellite meeting held at the site of the Research Society on Alcohol conference to focus on translational innovations in sex and gender differences in alcohol use.